LONG-TERM FOLLOW-UP OF OBESE SUBJECTS WHO ATTAINED IDEAL BODY WEIGHT

Natural history of weight loss maintenance of obese persons. Factors predictive of weight loss maintance. Comparison of weight loss maintenance with other intervention strategies.